Socio-spatial Networks and Tuberculosis Infection in Youth in Rural Uganda

PROJECT SUMMARY/ABSTRACT
The burden of tuberculosis (TB) in children and adolescents is massive and current TB control strategies, even
at full scale-up, are insufficient to address it.4,6-8,10 Novel strategies to expand TB control outside of the home
and into the community, where children acquire an estimated 80% of new TB infections,11-12 are urgently
needed. However, an incomplete understanding of where and from whom youth acquire TB, and how these
drivers change throughout the early life-course, hampers the design of novel interventions. Thus, we propose
the first-ever population-representative, longitudinal TB Infection Incidence Cohort of youth ages 1 to 18 years,
in rural communities in Uganda. Using a combination of epidemiologic and network analytic techniques, this
study will address key foundational knowledge gaps about TB transmission within 3 socio-spatial networks of
youth: the household network, the non-household social network (close contacts), and the network of casual
contacts encountered in community venues. In Aim 1 we will characterize the role of the household social
network in TB infection throughout the early life course. In Aim 2 we will employ social network analysis to
assess the relationships between child and adolescent TB infections and their community-based social
network, and in Aim 3 we will use location-based networks to assess the relationships between community
venues and incident TB infections in youth. Data from this proposal will directly inform novel, age-specific,
community-based TB control strategies and will help optimize existing household-based strategies.

Public health relevance
NARRATIVE There are significant gaps in our understanding of TB transmission dynamics among youth living in rural areas of East Africa. This proposal will use social and spatial network analysis to identify where, and from whom, children and adolescents acquire TB in rural Uganda. These foundational data will inform novel youth-specific interventions that are needed to expand TB control beyond the home to the community.